Data Management and Bioinformatics Core

Project Summary - Data Management and Bioinformatics Core
The Center for Viral Systems Biology (CViSB) produces vast amounts of rapidly changing, heterogeneous
systems biology data, creating a challenge in managing, tracking, and sharing data. The goal of the Data
Management and Bioinformatics (DMB) Core is to promote the reuse and understanding of the large,
multidisciplinary systems biology data we generate and curate. We aim to release as much of our data
and results as possible, as quickly as possible, by managing, tracking, and monitoring all CViSB activities
and data assets and publishing them on our CViSB Data Portal, data.cvisb.org. To aid in the
understanding of these data, we will develop approaches to improve the accessibility and interpretability
of our data through innovative bioinformatics software and visualization tools. Lastly, we seek to engage
with the community to promote the adoption and adaptation of our data and tools and to proliferate
FAIR-sharing best practices throughout the Systems Biology community.
To accomplish these objectives and support the overall mission of CViSB, we have the following four
aims: (1) Maintain and expand open data platforms for real-time sharing, tracking, and analysis of diverse
host, pathogen, and contextual FAIR data; (2) Harden and extend open bioinformatics pipelines and
computational tools for predictive modeling of diverse systems biological datasets; (3) Develop novel
visualization tools to aid in the interpretation and analysis of complex, multi-dimensional infectious
disease datasets; (4) Promote data management and bioinformatics activities beyond CViSB. Our
approach will enable a robust data and analysis ecosystem to provide multidimensional data in real-time
to CViSB and external researchers to understand virus dynamics.